Explosive Evolution Under Stress: The Driving Forces of Cancer Dynamics (Main)

The re-emergence of resistant cancer cells after initial therapy is one of the great unsolved, and deadly, problems in oncology, and a fundamental problem of evolution under stress. This project is aimed at understanding, from general principles of physics, ecology, and biology, why recurrence of resistant cancer cells seems to be a universal phenomenon in cancer. We believe that evolution in small, stressed habitats is the key to the rapid and inevitable re-emergence of resistance. The physical technology that drives this Project uses microfabrication of tiny, stressed habitats to test these Ideas. Modern techniques of physical probes, genomics, proteomics and nanotechnology will allow us to analyze the evolutionary path of these emergent resistant cells.

Public health relevance
RELEVANCE (See instructions): Perhaps the evolution of resistance in cancer is something we are making worse and ultimately more lethal with our present treatment of cancer. We hope that by truly understanding how resistance evolves, we may develop new therapies which control cancer to the point where it is survivable, if not cured.